MECHANICS OF LV SUCTION AND DIASTOLIC FILLING

To date, the mechanism underlying ventricular suction is unknown, and its role in maintaining physiological diastolic function is unproven. Ventricular suction is thought to play an important role in the almost explosive character of the early, rapid filling phase of the cardiac cycle (when much of ventricular inflow occurs); to contribute greatly to the diastolic filling necessary for efficient operation of the heart at rapid heart rates and with exercise; and to increase the overall efficiency of the heart by applying part of the mechanical energy of systole to power diastole. A failure of ventricular suction has been implicated in the excessively high left atrial pressures in the failing heart. The long range goal of the work described in this application is to determine the mechanical and structural basis for ventricular suction and elucidate the importance of diastolic suction to left ventricular filling under both physiological and pathophysiological conditions. This goal is now attainable due to three recent advances in our laboratories: First, the ability to acquire, by automated computerized analysis of stereo videoradiograms of implanted radiopaque markers, hundreds of simultaneous three-dimensional strains throughout the entire left ventricular myocardium; Second, a new experimental technique for left atrial pressure clamping and left ventricular volume clamping (servo-controlled) which shows promise in preliminary tests of revealing, for the first time, the mechanical correlates of left ventricular suction; and Third, a new computer graphics approach to visualization of large numbers of simultaneous instantaneous regional strains and shears allowing recognition of patterns, both spatial and temporal, not otherwise recognizable in the myriad of data arising from studies such as these. The proposed studies address the following questions: (1) What is the range of suction pressures which can be developed in the presence of a normal mitral valvular apparatus? (2) What is the importance of the contribution of suction to left ventricular filling? (3) Is elastic energy stored in myocardial torsional deformation, transmural compression, in-plane strains, or combinations of these shears and strains? (4) What are the regional distributions of elastic recoil and the sequence of regional energy release during diastole and how do these influence gradients of pressure within the LV? (5) What fraction of total LV filling can be accounted for by the mitral valve engulfing blood as it recoils toward the left atrium? (6) What are the effects of the pathophysiological conditions accompanying (a) volume overload hypertrophy and (b) pressure overload hypertrophy on regional diastolic mechanics, the storage of elastic energy during systole and its release during diastole, and the capability of the LV to develop suction? and (7) In what sequence and what proportion is energy stored in and released from the connective tissue matrix and the myocytes to aid filling? The answers to these questions should provide important new information regarding these fundamental aspects of diastolic function.